Structural Investigations Critical to Understanding DNA Damage Recognition and Repair in Cancer

SUMMARY
The human genome is under constant threat of damage through both exogenous (ultraviolet rays, chemicals
from cigarette smoke) and endogenous (oxygen for normal cellular respiration) sources. Safeguarding genomic
integrity from damage is fundamental to human health and prevention of disease states including premature
aging and cancer. While cellular oxidation-reduction systems exist for detoxifying a number of the metabolic
byproducts, some fraction inevitably escapes to generate oxidized lesions in DNA. The damage can take the
form of free radical damage to bases allowing mispairing during replication, sites of base loss and strand breaks.
Cells endure tens of thousands of these sites of damage per day that, if left unrepaired, lead to cancer, cancer
progression or render treatment regimens ineffective. Understanding the means by which these sites of damage
are recognized and repaired error-free or bypassed in error-prone manners is essential to provide critical
information regarding predictive outcomes and therapeutic strategies for cancer patients. This proposal utilizes
biochemical, biophysical and structural biology techniques in support of two NCI-funded Programs aimed at
elucidating the molecular details of key enzymes involved in DNA repair. Program 1 investigates structural and
biochemical details of DNA polymerase β to determine mechanistic features governing the loss of replication
fidelity observed for variants in the human population including those found in cancer. Pol β is responsible for
filling DNA gaps generated by glycosylases of the base excision repair pathway upon excision of oxidative
damages. Program 2 investigates the structural domains of the POLQ gene product DNA polymerase θ and its
response to encountering unrepaired DNA during replication, in particular the processing of DNA double strand
breaks in an error-prone manner during theta-mediated end joining (TMEJ). Upregulation of the POLQ gene
strongly correlates with poor clinical outcome in breast cancer patients and Pol θ has emerged as a compelling
drug target for combination therapy with radiosensitization. I serve diverse roles within this proposal including
integration of multiple technical approaches to investigate protein interactions with damaged DNA from both
Programs while characterizing functional or patient-derived variants of the enzymes. Additionally, I maintain the
X-ray and structural biology support equipment while guiding trainees in their lab work under the NCI programs.
Moreover, support from this proposal will allow generation of preliminary data for additional NCI proposals that
synergistically complement the currently funded programs, in particular the renewal of the previously funded P01
program investigating DNA glycosylase structure and mechanism (Program 3). Collectively, this work is expected
to generate important insights into the molecular mechanisms of DNA repair proteins. This proposal is expected
to have a positive impact for NCI research because the detailed knowledge of enzyme molecular mechanisms
coupled with studies of cancer variants will increase our understanding of cancer susceptibility and optimize
treatments.

Public health relevance
PROJECT NARRATIVE The proposal herein investigates the structural details of key enzymes, DNA pol β and DNA pol θ in particular, involved in DNA damage recognition, repair, or bypass and aims to uncover the molecular details leading to error-free vs. error-prone DNA synthesis. Aberrant repair processes utilizing these enzymes lead to disease states and circumvent therapeutic interventions in cancer. The synergy between these research programs utilizes my expertise in multiple biophysical and structural biology techniques to advance mechanistic understanding of genomic instability in cancer.